GATORAADE: Gators Advancing Through Opportunities in Research for Aging and Alzheimer's Disease Education

The Gators Advancing Through Opportunities in Research for Aging and Alzheimer's Disease Education (GATORAADE) Program aims to expand the pool of researchers and healthcare workers interested in brain aging and Alzheimer's disease and related dementias (ADRD).
The GATORAADE program will target undergraduate students in their final year and will offer a tailored postbaccalaureate program. Students will be expertly matched with research mentors aligned with their professional goals, will be provided personalized
career mentorship and hands-on laboratory experience and extensive resources. Additionally, GATORAADE trainees will complete an academic curriculum that covers brain aging, ADRD, and risk factors.
Our Objectives for GATORAADE trainees include:1) to develop an understanding of cognitive aging and ADRD research through mentorship, didactic instruction, and networking opportunities; 2) to enhance the trainee’s scientific efficacy via mentored hands-on research training in aging and ADRD; 3) to foster an understanding of
experimental design and data interpretation in cognitive aging research; 4) to cultivate professional communication skills through research presentations at conferences; 5) to facilitate awareness of graduate and professional school alternatives tailored to the trainee’s career goals and to coach them through the application process; 6) to promote matriculation into graduate or clinical training programs related to aging and ADRD.
Overall, the GATORAADE program emphasizes three core competencies: 1) Technical development of research skills in aging and ADRD, with 20 students receiving year-round hands-on laboratory training (up to two years) guided by a personalized mentorship committee; 2) Didactic instruction of foundational knowledge in aging and
ADRD mechanisms through a 12-credit academic program, after which students will obtain a University of Florida (UF) Online Biomedical Neuroscience Certificate; 3) Preparation in useful scientific skills for career advancement in aging and ADRD research and related healthcare fields, including effective communication and support
throughout graduate/professional school applications.
The GATORAADE program aims to bridge representation knowledge gaps and enhance the workforce in brain aging and ADRD fields. By combining research experiences, academic instruction, and career development support and coaching, GATORAADE trainees will be equipped with foundational knowledge and meaningful skills to pursue graduate or clinical training programs. Retaining these individuals will
contribute to reduce risk factors and to improve our chances of combatting aging related
neurological conditions.

Public health relevance
The University of Florida Gators Advancing Through Opportunities in Research for Aging and Alzheimer's Disease Education (GATORAADE) Program aims to provide comprehensive research training and didactic instruction to postbaccalaureate trainees interested in advancing our understanding of brain aging and Alzheimer's Disease and related dementias (ADRD). By addressing the behavioral, socioeconomic, biological and clinical aspects of brain aging and ADRD, the GATORAADE program will contribute to increase the pipeline of researchers and healthcare professionals thus enhancing the environment and workforce in the aging and ADRD fields. In alignment with the National Institute on Aging (NIA)'s mission of fostering the development of research and clinician scientists in aging, the GATORAADE program will also empower early career researchers and pre-health professionals to gain a deeper understanding of aging and related disorders, and its impact on public health outcomes.